CYSTIC FIBROSIS--STEROID THERAPY ON PULMONARY FUNCTION AND AIRWAYS REACTIVITY (HU

We will evaluate the effect of one week of daily, low dose prednisone therapy in CF patients by following airway responsiveness to mecholyl challenge and pulmonary function tests, pre- and post-bronchodilator therapy.